Optimizing Carbon Ion Therapy for Pediatric CNS Tumors

SUMMARY
Primary central nervous system (CNS) tumors are the most common solid tumors in children and the leading
cause of childhood-cancer-related deaths. Thus, there is an urgent need to identify novel therapeutic treatments.
One such advancement is carbon-ion radiation therapy (CIRT). Yet, despite treating 20,000 patients over 2
decades, there is a significant reluctance to use this modality to treat pediatric brain tumors because of a fear
that normal tissue would be irreparably harmed. This fear is a consequence of the many questions that are
unanswered regarding the ability to quantify the relative biologic effectiveness (RBE) of CIRT. An important
attribute of the physical dose delivered by charged particles is ionization density, which varies with particle charge
and velocity. Ionization density is frequently described in terms of linear energy transfer (LET), defined as the
mean energy lost 𝑑𝐸∆/𝑑𝑙 by a charged particle per unit distance 𝑑𝑙 traversed due to interactions with electrons
in matter. For charged particles, the dose and LET increase dramatically over the terminal few millimeters of the
pristine Bragg peak as the particle halts. A major uncertainty is the scaling from dose and LET to biological effect,
which varies within tumors and normal tissues in a complex manner. The computational dose and RBE models
simulate on a millimeter-scale the variation of dose, energy and LET spectra, and particle fragment spectra within
the patient anatomy and link these physical properties to biologic data, often determined from in vitro clonogenic
survival assays. A critical gap in knowledge is the true in vivo tissue response to high-LET radiation in clinically
relevant biological assays. The uncertainty is enormous and the impact of incorrect assignment of an RBE value
to a given voxel can be catastrophic in clinical practice. Therefore, RBE values need to be determined with the
greatest possible accuracy. Our central hypothesis is that optimization of carbon-ion radiation therapy will
allow for improved curative outcomes for pediatric brain tumors, with equivalent or lower neurologic
toxicity compared to x-ray therapy. Two specific aims will be used to test the hypothesis. Aim 1 will
systematically quantify the RBE of CIRT normal-tissue toxicity in a rodent model of pediatric brain, for various
functional and pathologic endpoints, at variable dose and LET, compared to x-ray therapy. Aim 2 will test the
working hypothesis that high-LET carbon ions are more effective in controlling pediatric high-grade glioma than
conventional radiation. Thus, the overall objective of this work is to investigate the normal brain toxicity, cognitive
side effects, second cancer risks, and anti-tumor efficacy in preclinical models relevant for pediatric patients,
providing a sound foundation for advancing this modality into clinical practice. We will answer the question as to
whether carbon-ion therapy, which shows immense potential for historically radioresistant cancers, can be
expected to improve the therapeutic window for pediatric high-grade glioma patients. Furthermore, we will
contribute fundamental new knowledge regarding treatment risks and neurotoxic side effects relevant for all
pediatric CNS tumors treated with radiation.

Public health relevance
NARRATIVE Carbon-ion radiation therapy (CIRT) has the potential to improve survival of adult patients with radioresistant brain tumors due to its physical dose distributions and its high linear-energy transfer, making it possible to treat brain cancer using less radiation dose than x rays or protons. However, for younger pediatric patients undergoing critical stages of brain development, the question shifts: what are the risks of functional neurotoxic and other late side effects? This critical and unanswered question is addressed by systematically quantifying the 1) RBE for CIRT-mediated normal-tissue toxicity in a rodent model of pediatric brain and 2) efficacy for CIRT in a preclinical rodent model of pediatric glioma.